Unraveling the Role of Tandem Repeats and Structural Variants in Addiction-Related Behaviors Using Heterogeneous Stock Rats

Project Abstract
Drug abuse is a significant public health crisis, with over 106,000 drug-involved overdose deaths in the U.S. in
2021. Human genome-wide association studies (GWAS) have started to identify underlying causal genetic loci
in addiction, but most of them sacrifice phenotypic granularity in order to obtain larger sample sizes. GWAS in
model organisms such as N/NIH heterogeneous stock (HS) rats provide a valuable alternative that bridges this
gap. However, determining the causal genes of addiction remains challenging because most GWAS studies
focus on single nucleotide polymorphisms (SNPs) and overlook complex variants such as and tandem repeats
(TRs) and structural variants (SVs). TRs and SVs are longer genome alterations compared to SNPs, which
makes them hard to detect with short-read sequencing. This project proposes to address this serious limitation
by using cutting-edge long reads sequence to discover and genotype TRs and SVs in support to investigate their
roles in drug abuse using HS rats. The central hypothesis is that TRs and SVs contribute to the variability in
gene expression, hence, affecting addiction-related behaviors in HS rats. In Aim 1, the TRs and SVs landscape
in HS rats will be characterized using newly generated long reads in both inbred HS founders and outbred HS
rats. Then, in Aim 2, a computational package will be developed to impute TRs and SVs to the whole population
of over 20 thousand outbred HS rats. Finally, in Aim 3, quantitative trait loci mapping analysis will be performed
to link TRs and SVs to gene expression and addiction-related behavioral traits. This innovative approach
integrating long-read sequences focuses on underrepresented genetic variants, providing new insights into
addiction genetics and potentially uncovering novel genetic mechanisms influencing addiction-related behaviors.
Completion of this project will not only provide with the applicant with valuable training in behavioral genetics
and bioinformatics and lead to potential therapeutic targets and strategies for preventing and treating drug abuse,
but also create a community resource that will enhance ongoing rat genetic studies.

Public health relevance
Project Narrative The effect of complex genetic variants, such as tandem repeats and structural variants, on drug abuse remains poorly understood due to the difficulty of identifying them. This proposal focuses on employing new long-read sequencing technologies and developing new computational methods to overcome this obstacle, aiming to unravel novel genetic mechanisms behind tandem repeats and structural variants that could lead to better prevention and treatment strategies for drug abuse. This training proposal will provide the applicant with training in bioinformatics and behavioral genetics.